Asymmetric Deoxygenative Diversification of Alcohols and Carboxylic Acids

Project Summary
This proposal centers on developing new deoxygenative functionalization of alcohols and carboxylic acids for
accessing medicinally valuable chiral amines and fluorinated compounds through new sequential, stereo-
controlled reactions. Alcohols and carboxylic acids are ubiquitous, structurally diverse, and stable feedstock
chemicals, making the asymmetric deoxygenative diversification of their C–O bonds a highly attractive strategy
for exploring new chemical space and discovering new therapeutics. While seminal approaches have
demonstrated converting alcohols and carboxylic acids to pharmaceutically relevant chiral products, these
methods often require multiple steps, undergo slow C–O bond activation, are limited in nucleophile scope, and
lack stereo-control. To overcome these challenges, the Kim Group will employ a sulfonyl fluoride as a SuFEx
(Sulfur Fluoride Exchange) clickable reagent for alcoholic C–O bond activation and a catalytically versatile base
metal that will facilitate multiple C–O bond functionalizations of carboxylic acids. Our methods will allow one-
step, rapid asymmetric C–O bond derivatization to construct C(sp3)–N/C bond formations between
unfunctionalized starting materials and diverse nucleophiles with predictable stereochemical outcomes. Herein,
we will develop the following Research Programs: (1) One-step, stereospecific and site-selective deoxygenative
amination and perfluoroalkylation of alcohols via SuFEx, allowing direct installations of pharmaceutically relevant
free amines, N-heterocycles, and perfluoroalkyl groups into alcohols, and (2) enantioselective deoxygenative
diversification of carboxylic acids, providing a new platform for chiral amine synthesis via sequential geminal C–
O bond functionalizations of a carboxyl group. Together, the successful realization of the goals described in
these research programs will provide a new set of robust tools for rapid asymmetric derivatization of C–O bonds
within widely available feedstock chemicals and complex molecules, which will expedite synthetic access to
medicinally valuable products.

Public health relevance
Project Narrative This proposal focuses on advancing new synthetic technologies for directly diversifying alcohol and carboxylic acid feedstock chemicals. We will uncover new cascade, stereo-controlled chemical reactions by employing multifunctional reagents and catalytically versatile metals to address the long-standing challenges in synthetic organic chemistry. Our research programs are expected to deliver new chemical tools that will accelerate access to biologically relevant molecules, which will aid in discovering the next generation of therapeutics.